Characterizing a High-Reliability Implementation Program for Sepsis: Sepsis Tools AND Accurate Reporting of Outcome Differences (STANDARD) Study

PROJECT SUMMARY
Sepsis is the most common cause of death in U.S. hospitals, and hospital risk-adjusted sepsis mortality varies
by more than 40%—suggesting that an estimated 20,000 sepsis deaths could be avoided if top-performing
sepsis care were delivered more widely. Sepsis quality improvement activities have focused on reducing
variation in early clinical care, but the ways in which performance improvement (PI) is implemented vary
widely. Trauma systems and other disease-specific regionalization programs have achieved impressive
mortality reduction through standardized implementation of PI. The overall objective of this project is to identify
organizational features and PI implementation practices likely to reduce sepsis mortality and then to validate
that these practices are associated with improved outcomes. Our central hypothesis is that PI implementation
practices (e.g., multidisciplinary sepsis committee, case review, use of an institutional sepsis registry) observed
in top-performing hospitals can be adapted and widely applied to lower-performing hospitals to improve sepsis
clinical outcomes. The specific aims of the proposed study are to (1) identify hospital-level implementation
strategies and PI activities being used in top-performing hospitals, (2) validate the relationship(s) between
specific implementation strategies and sepsis performance, and (3) develop consensus regarding
implementation strategies most likely to be impactful in lower-performing hospitals using a community-engaged
approach. The proposed project will accomplish these aims by (1) conducting site visits at 10 top-performing
hospitals and 6 lower-performing hospitals identified based on hospital risk-adjusted sepsis mortality and
performance on the sepsis quality reporting metric (SEP-1); (2) identifying PI implementation strategies that
are related to low sepsis mortality; (3) conducting an inventory of PI activities identified in site visits in a
national sample of 560 hospitals to measure the association between PI and clinical outcomes; (4) identifying
those strategies most strongly associated with improved clinical outcomes; and (5) convening a panel of
experts with practical knowledge and experience to identify strategies using a modified Delphi method that are
most promising to implement feasibly in lower-performing hospitals. After successful completion of the
proposed project, we expect to have identified organizational features and successful PI implementation
strategies at top-performing hospitals (Aim 1) and validated those strategies in a larger sample of U.S.
hospitals (Aim 2). Then we expect to have identified the most promising among those strategies for future
implementation (Aim 3). These results will have a positive impact because they will serve as an important
resource for developing best practices for sepsis PI implementation that have the potential to improve hospital
performance and therefore reduce preventable sepsis deaths.

Public health relevance
PROJECT NARRATIVE Sepsis is the most common cause of death in U.S. hospitals, and hospital risk-adjusted sepsis mortality varies by more than 40%—suggesting that an estimated 20,000 sepsis deaths could be avoided if top-performing sepsis care were delivered more uniformly. Using Medicare claims, hospital quality performance, site visits at top-performing hospitals, and a hospital telephone survey, this study will identify performance improvement (PI) implementation strategies at top-performing hospitals and validate that these activities are more common among top-performers in a U.S. national hospital survey. The findings from this study will be used to standardize the process of sepsis PI implementation, thereby reducing variation between hospitals and improving sepsis survival.